Immunologic Characterization of CSF microglia in multiple sclerosis

ABSTRACT
Microglia are long-lived, self-replicating, yolk sac-derived immune cells of the central nervous system (CNS)
parenchyma that are critical modulators of immunity and neuropathology. Microglia dysfunction contributes to
several neurologic diseases, including multiple sclerosis (MS). In our preliminary studies, we have
unexpectedly identified microglia circulating with the cerebrospinal fluid (CSF) of patients with MS. We
hypothesize that CSF microglia are endogenous CNS cells that exhibit signatures unique to neurologic disease
states. We aim to identify any disease-associated characteristics of CSF microglia. We will explore the number
and immunologic features of CSF microglia in MS by flow cytometric analysis. To explore the molecular
signature of CSF microglia in various disease states, we will perform single cell RNA sequencing on sorted
CSF microglial cells. Comparisons will be made between gene expression patterns in CSF microglia between
MS in relation to healthy control subjects to determine the health- and disease-specific profile of these cells.
Finally, we will pursue immunologic phenotyping both by flow cytometry and transcriptomic analysis in MS
patients before and after treatment. This proposal will lay the groundwork for the characterization of a novel
cellular population capable of regulating CNS immunity.

Public health relevance
PROJECT NARRATIVE Our observation that microglia - key innate immune cells of the central nervous system - are found circulating with cerebrospinal fluid of patients with multiple sclerosis (MS), has led us to hypothesize that these cells are phenotypically unique in different diseases. We will examine patients with MS to determine any disease- specific features of CSF microglia and explore the nature of these cells before and after disease-modifying therapy.